Generation Mechanisms of Memory-Related Internal Sequences in the Hoppocampal CA1 Region

Project Summary/Abstract
Episodic memory is the memory that allows us to mentally re-experience specific episodes from our personal
past. During memory encoding, the continuous stream of experience is segmented into individual episodes,
where each episode encodes a sequence of events ordered in time. Yet, how neural circuits perform
computations to segment experience and encode sequentially occurring events remains unknown. Revealing
the circuit-level mechanisms behind these computations is essential for understanding episodic memory in both
health and disease. In the hippocampus, a brain area essential for episodic memory, neurons are sequentially
activated as an animal travels through an environment. The sequential firing of these so-called place cells
repeats each time the animal revisits the same path, as if the animal’s previous experience of traversing the path
is recollected. However, rich sensory cues are present in every environment, making it difficult to assess how
much of the spiking activity in the place cell sequence is independent of direct sensory inputs. Reversibly toggle
sensory inputs on and off during locomotion has made it possible to isolate the sequential activity produced by
the internal computation (internally generated sequences (IGSs)) from that driven by sensory inputs. These IGSs
that occurred during locomotion coincide with the performance of memory tasks, suggesting that they are
memory-related sequential activity patterns. Interestingly, IGSs reoccur in each trial of a memory task and
sometimes appear following spontaneous locomotion onset, implying that hippocampus can identify behavior-
level boundaries and encode specific segments of experience. Revealing the neural circuits that underlie the
expression of IGSs within a segment of experience such as a single behavior trial will provide new insight into
how continuous experience is segmented and selectively encoded. The objective of this study is to elucidate
the circuit-level mechanisms that evoke IGSs, and test the hypothesis that distinct types of interneurons in
hippocampal CA1 coordinately modulate the state of the pyramidal neuron population thus gating IGS expression.
Accomplished in three aims, we will employ a multidisciplinary approach encompassing the use of in vivo
functional recordings, cell-type specific chemogenetic and optogenetic perturbations, and behavioral analysis to
identify the behavioral conditions required for IGSs to occur, and determine how two distinct types of interneurons
coordinate to signal the start of integration and control the window of integration, thus gating the occurrence of
IGS. Completion of these aims will contribute to novel insights into how neural circuits operate to segment
experience and encode episodic memory, and what can go wrong under pathological conditions such as
dementia and Alzheimer’s disease where impaired episodic memory profoundly impacts the patients’ quality of life.

Public health relevance
Project Narrative Episodic memory is a unique type of memory that enables us to mentally travel back in time to re-experience specific episodes that occurred in our lives. During memory encoding, continuous experience is segmented into episodes each encoding a sequence of temporally organized events; however, little is known about the neural circuits that perform computations to segment experience and encode sequential events. Revealing how the hippocampal circuits perform these computations will provide key insights into understanding episodic memory both in health and in pathological conditions such as dementia and Alzheimer’s disease where patients’ life quality is profoundly disrupted due to impaired episodic memory.